Admin_Core

PROJECT SUMMARY/ABSTRACT (ADMINISTRATIVE CORE)
The objective of the Administrative Core of the University of Pennsylvania Telehealth Research Center in
Cancer Care (Penn TRC) is to ensure that the impact of the Center is greater than the sum of its parts. The
Administrative Core will accomplish this objective by maximizing collaboration and synergy across the
Research and Methods Core, Clinical Practice Network, and Pragmatic Trial. The Penn TRC’s cohesive
organizing framework addresses the fundamental question of how to leverage insights from communication
science and behavioral economics to design and test innovative telehealth strategies for care delivery to
improve effectiveness and equity across the cancer care continuum, with an emphasis on understanding
mechanisms of action. The Administrative Core will provide overarching strategic, operational, and scientific
oversight to achieve this organizing framework. The specific aims of the Administrative Core are to: 1) Provide
essential leadership and integration of all Penn TRC activities; 2) Create interdisciplinary research capacity
and collaborations; 3) Coordinate communication and dissemination of research findings, evidence-based
telehealth strategies, care delivery models, and other resources to scientific audiences and other relevant
stakeholders; and 4) Monitor and evaluate Penn TRC progress and leverage findings to inform iterative
refinement of Penn TRC activities and plans for future research. Completion of these aims will create a culture
of exceptional interdisciplinary science and ensure success by stimulating and guiding new methodological
advancements, building capacity for cancer care delivery research, and generating a robust evidence base for
patient-centered, sustainable telehealth models of care at Penn and nationally. The Administrative Core
leadership will ensure that the Penn TRC fulfills the National Cancer Institute’s vision to advance a national
telehealth research agenda focused on improving cancer-related care and outcomes across the cancer care
continuum in a rapidly changing health care, policy, technology, and communication environment.